The Left and Right Ventricles in Sleep Apnea with COPD

Abstract
Dr. Janna Raphelson is a Pulmonary Critical Care fellow at UCSD and she is applying for this F32 grant to
further her development as an academic physician scientist. Throughout the time period of this award she
hopes to develop an expertise in heart/lung/sleep physiology that will be the foundation of her path to
independence as a clinician researcher. She will also pursue proficiency in biostatistical methods and trial
design through formal coursework and direct mentoring, and gain exposure to the field of control of breathing.
Her specific project for this period will focus on cardiovascular outcomes in patients with comorbid obstructive
sleep apnea (OSA) and chronic obstructive pulmonary disease (COPD), referred to as overlap syndrome
(OVS). To our knowledge, no randomized trials have been performed in OVS leaving a major void regarding
how best to treat >1% of the adult US population. The proposed work is a mechanistic study to evaluate the
underlying mechanisms behind increased cardiovascular risk in patients with OVS compared to patients with
COPD or OSA alone. The central hypothesis is that poor outcomes in OVS vs. COPD or OSA alone are driven
by right and left heart remodeling which is more pronounced when exposed to both sustained and intermittent
hypoxia in OVS as determined by cardiac MRI imaging metrics. Aim 1 will test the hypothesis that RV
remodeling (as measured by RV mass index, primary outcome) will be more elevated in patients with OVS
compared to patients with COPD or OSA alone. Given the high vascular risk among afflicted patients, the very
high population prevalence of disease, and the lack of current data, further mechanistic research is imperative.
Aim 2 will assess the ability of the BODE index, a commonly used clinical tool to predict mortality in COPD, to
predict cardiac changes as seen on cardiac MRI. Exercise capacity limitations (an important component of the
BODE index) have been linked to myocardial fibrosis and LV remodeling, thus in Aim 2 we hypothesize that
high BODE index scores will predict a greater degree of myocardial fibrosis (primary outcome) and increased
LV remodeling index (secondary outcome) by cardiac MRI in patients with COPD. This grant period will help
launch Janna’s academic career as she is highly focused and deeply committed to making a scientific impact
on patients afflicted with pulmonary and sleep related disease. She is working in a highly supportive
environment with a mentoring team with a proven track record, and she is passionate about her vision of
becoming a leading physician scientist running an NIH funded laboratory in the coming years.

Public health relevance
Project Narrative Overlap syndrome is a common condition with devastating cardiovascular consequences, but research into this condition can be difficult due to heterogeneity in the severity of obstructive lung disease and apneas. The goal of this mechanistic research study is to determine key indicators of cardiac dysfunction by cardiac MRI assessment. The findings of this study may redefine the condition clinically by its adverse cardiac changes rather than by traditional paradigms.